Child and Adolescent Psychiatry Research Institute (CAPRI): A National Child/Adolescent Psychiatry Research Mentorship Network

Project Summary/Abstract:
BACKROUND: NIMH and the National Academies of Sciences, Engineering, and Medicine have identified a
critical shortage of child and adolescent psychiatry (CAP) researchers—paradoxically as most mental
illnesses are recognized as having developmental origins, with impact across the lifespan. CAP physician-
scientists are a critical part of the multi-disciplinary research workforce (including PhDs from myriad disciplines)
uniquely trained to bridge the gap between basic science and clinical translation. CAP physician-scientists are
crucial to NIMH achieving its Strategic Objectives—and vital to making substantial public health impact by
developing early detection, treatment, and prevention strategies that are effective, lasting, and resilience-
promoting. We seek to establish the Child and Adolescent Psychiatry Research Institute (CAPRI) a
national research mentorship network (PAR-23-263) seated at the American Academy of Child and
Adolescent Psychiatry (AACAP)—the national home of CAP physicians. CAPRI will address the
shortage of CAP physician-scientists by: (1) recruiting overlapping cohorts of 12 CAP-trained/committed
early career researcher “Scholars”; (2) providing a 2-year mentorship program, with (a) 3-day meeting at
the AACAP Annual Meeting, (b) monthly web-based career development seminars, (c) quarterly Scholar and
Mentor meetings, (d) home institution mentor integration; (3) shore up the CAP research pipeline by (a)
reaching earlier via Short Course for 12 pre-contemplative CAPs not ready for a K-award and sustaining
mentorship for Summer Medical Students, (b) enhancing retention via annual reunion & online community,
and (c) reducing attrition by creating social-belonging communities for structural barriers of race, gender,
ethnicity. Scholars will learn vital skills to begin and maintain a successful research career—scientific writing,
communication and negotiation skills, time management, giving/receiving mentoring, project management,
responsible conduct of research, and enhancing statistical knowledge and collaboration. Key Innovations:
(1) exclusive CAP focus to build a sustainable network with common experience; (2) substantial subject-
specific expertise and targeted Mentor-matching; (3) home institution mentor integration; (4) evidence-proven
science of mentoring practices from established R25s, Center for Improvement of Mentored Experience in
Research, and leaders in diversity/inclusion. Our primary outcome is Scholar submission of “K” career
development awards. Secondary outcomes are Scholar and Pre-contemplator development as academic
leaders by independent grant support, publications, presentations, academic promotion, mentorship, and
scientific service—and medical students entering psychiatry residencies. CAPRI is significant because we
directly address NIMH’s “Blueprint for Change: Research on Child/Adolescent Mental Health” and Institute of
Medicine goals to bolster the CAP research workforce via tiered, targeted, and sustaining mentorship.

Public health relevance
Project Narrative: The number of child and adolescent psychiatry (CAP)-trained/committed physicians pursuing a research career is declining paradoxically at a time when there is greater need for CAP physician/scientists to advance the NIMH Strategic Plan, including increasing recognition that neuropsychiatric illnesses are often disorders of neurodevelopment, starting early in childhood/adolescence. The Child and Adolescent Psychiatry Research Institute (CAPRI) will create a national mentoring network: (1) linking early career CAP-trained/committed researchers (CAPRI Scholars) to established CAPRI Mentors for a 2-year mentorship program of overlapping cohorts, engaging in a 3-day in-person meeting plus ongoing webinars and regular 1:1 mentor meetings throughout the academic year; (2) providing mentorship for pre-contemplative CAP physicians not yet ready to apply for a K-award in preparation to become Scholars; and (3) providing sustaining mentorship for AACAP Summer Medical Students to increase their likelihood of choosing psychiatry and ultimately CAP as a career. CAPRI will mentor the next generation of CAP researchers, increasing their success in obtaining career development awards, launching their careers to improve mental health, and providing a sustainable support network and social belonging.